Cerebral oscillations of pain

Summary
Chronic pain disorders are amongst the most burdensome of all diseases in terms of their impact on the
individual and the costs to society. The development of novel therapeutic approaches for chronic pain have
relied on basic studies involving genetic and molecular approaches in rodent models of pain, but existing drugs
generally provide very limited relief for only a small number of patients. The result is that a vast number of
people with chronic pain go untreated and have only partial relief. There is substantial and growing evidence
from within and outside the pain research fields that indicates neural oscillations reflect cognitive, emotional,
and sensory processes, which are all components of the pain experience. Furthermore, we can target these
oscillatory patterns to alter perception. In particular, alpha band activity has been associated with chronic pain,
and our extensive recent work and preliminary findings indicate that alpha can reliably predict future sensitivity
to pain experienced minutes to weeks in the future in healthy subjects. In the proposed studies, we use
simultaneous EEG-fMRI to continue our ongoing work on alpha oscillations as pain mechanisms and extend it
to test the specificity and sensitivity of the signals and the relationship between alpha, brain networks, and
pain. The proposed work would lead to improved understanding of the neurobiology of pain, identify novel
brain targets for new or improved interventions, and potentially reveal a prognostic biomarker that would be
useful for testing new therapeutic approaches and objectively assessing clinical improvement on an individual
basis.

Public health relevance
Narrative Development of treatments for chronic pain has been limited, but the potential for using brain signal predictive and prognostic biomarkers is growing. In the proposed studies we aim to understand the mechanisms of an electroencephalogram (EEG) based brain oscillation that predicts pain sensitivity in healthy subjects. The findings will provide a major step forward in the development of novel therapies for chronic pain and individualized treatment approaches.